Path B Enhance the Capacity and Capabilities of Tennessee's Produce Safety Program in Support of an Integrated Produce Safety System

Project Abstract
The goal of this project is to assist the State of Tennessee in implementing an integrated produce
safety system. It is the aim of the Tennessee Department of Agriculture to be a key component in
execution of an integrated produce safety system across the United States. Multiple activities will be
supported through this project including a robust produce safety inspection program. Personnel,
training, and travel will all be key line items utilized within this project. TDA will be applying under
Path C. The Produce Safety Rule (PSR) has been adopted by reference therefore state authority to
conduct inspections is present. A link to TDA's produce inspection authority is listed below.
https://publications.tnsosfiles.com/rules/0080/0080-04/0080-04-15.20200212.pdf

Public health relevance
Produce Safety Cooperative Agreement Proposal Narrative Throughout the first five years of engagement in the Produce Safety Cooperative Agreement the Tennessee Department of Agriculture (TDA) adopted the Produce Safety rule by reference, conducted on-farm produce inspections, and provided education/outreach to stakeholders. Moving forward, continued funding support is requested to assist TDA in providing similar services throughout the State. This funding will ensure TDA has the resources and infrastructure necessary to sustain and enhance the State’s produce safety activities with special focus on mitigating outbreaks or other events that could lead to illness.